Neurocognitive Effects of Type 1 Diabetes in Young Children: Indiana University Clinical Center

PROJECT SUMMARY
Many individuals living with Type 1 diabetes (T1D) experience significant cognitive impairments. These
impairments are more common in people diagnosed in early childhood, particularly under 5-6 years of age, and
are associated with measurable neuropathologic brain structure changes. Across the lifespan, these cognitive
difficulties can impact adaptive functioning, academic performance, and disease management. Strategies to
decrease the likelihood of cognitive deficit development are needed.
The study we propose in this application is designed to address current gaps in our knowledge regarding the
underpinnings of neurocognitive changes in persons living with diabetes. We anticipate that it would be
implemented by a multicenter collaborative effort of pediatric endocrinologists, psychologist, and radiologists
whose ultimate goals are to: 1) better understand the impact of T1D on the developing brain; 2) identify and
evaluate potential risk and protective factors associated with T1D-related neurocognitive impact; and 3) assess
potential associations between use of newer and emerging diabetes management technologies and
neurocognitive functioning among children with T1D.
With this application we propose two aims to achieve these goals: Firstly, we propose to characterize
associations of cognitive function and brain structure with clinical and environmental parameters in
children with T1D enrolled at 6-<8 years of age relative to healthy controls. Children will be assessed at
baseline and 18 months, with every 3-month interval clinical assessments including measures of glycemia.
Secondly, we propose to enroll a second younger cohort of children 3-5 years of age and follow them
prospectively with regular glycemic data collection until they undergo cognitive assessments and neuroimaging
at 6-8 years of age to characterize the relationship of early glycemic exposure (assessed primarily using
time in optimal glycemic range) to subsequent cognitive function and neuroimaging metrics.
With our application, the Indiana University Clinical Center pledges to work collaboratively with other consortium
sites, a biostatistics research center, and patient partner stakeholders to develop and implement a uniform
protocol. This protocol will entail recruiting diverse cohorts of prepubertal recently-diagnosed children with type
1 diabetes and healthy controls, following participants longitudinally, and performing neurocognitive
assessments and imaging. Success will ultimately be measured by the consortium determining mechanisms
underlying cognitive dysfunction in very young persons with T1D. Once modifiable determinants have been
elucidated, strategies to optimize neurocognitive functioning for persons with T1D throughout the lifespan will be
possible.

Public health relevance
PROJECT NARRATIVE Many individuals living with Type 1 diabetes (T1D) experience significant cognitive impairments, and strategies to decrease the likelihood of this chronic disease complication are needed. With this application, we propose a study to be implemented by a collaborative multisite consortium that will work with stakeholder partners to address current gaps in our knowledge regarding the underpinnings of neurocognitive changes in very young children with T1D. Success will ultimately be measured by the consortium elucidating modifiable determinants, enabling strategies to optimize neurocognitive functioning for persons living with T1D throughout their lifespans.